Oral Health Education and Navigation Program for Older Immigrants with Limited English Proficiency

PROJECT SUMMARY
Building upon the evidence that limited English proficiency (LEP) poses a critical risk to older
immigrants' oral health and dental care, the proposed study focuses on older Korean Americans
as an initial target group for evaluating an oral health education and navigation program
designed to promote older LEP immigrants' use of preventive dental services. The study is
based on four premises: (1) oral health knowledge and healthcare navigation skills are critical
imperatives in reducing oral health disparities in LEP populations and, thus, are important
intervention targets, (2) bilingual and bicultural community health worker (CHW) participation is
critical in reaching out to older LEP immigrants, (3) language diversities in LEP populations, as
well as differences in personal needs, necessitate a sustainable method to personalize the
intervention (i.e., computerized tailoring), and (4) the combination of “human touch” (CHWs) and
“digital touch” (technology) requires a pilot test to evaluate feasibility and acceptability. The
program we envision is an oral health education and navigation assistance program that is
personalized by a computerized tailoring system and delivered by CHWs. The long-term goal of
the program, inspired by the Transtheoretical Model (TTM) and the Fogg Behavioral Model
(FBM), is to promote both proximal (oral health knowledge and self-efficacy) and distal (use of
preventive dental services) outcomes. As a first step toward the goal, this R21 study pursues
the following activities: (1) focus group with a Community Advisory Board, (2) assessment of the
local dental service environment, (3) content development for education and navigation
materials, (4) development of a computerized tailoring system, (5) development of protocols for
CHW training and monitoring, and (6) pilot testing and evaluation of the program. Each step will
be guided by the principles of Community-Based Participatory Research (CBPR). The products
from these initial activities will include a content library of oral health education materials and
local resources for dental care, a computerized tailoring system, and a protocol for CHW
training and monitoring. Pilot testing will be conducted with 40 older Korean Americans who
meet the eligibility criteria (having LEP and no use of preventive dental services in the past 12
months). Each participant will be assigned to one of four trained CHWs and will receive a
personalized one-on-one education session (30 minutes, using an iPad). The research team will
contact participants three months later to determine whether they had used any preventive
dental services since the education session. Using an adaptive design, a CHW-led personalized
navigation assistance program will be provided to non-users. The research team will collect and
analyze data from both the participants and the CHWs, including quantitative data on
participation rate and satisfaction with the program and qualitative feedback. The findings will
form a solid foundation for a larger, definitive study with a clinical trial (e.g., R01) to identify
behavioral health outcomes and provide a translational model for reducing barriers to preventive
dental services for diverse LEP groups.

Public health relevance
PROJECT NARRATIVE The Oral Health Education and Navigation Program for Older Immigrants with Limited English Proficiency application responds to the vulnerabilities of older immigrants with limited English proficiency (LEP) in oral health and dental care. Focusing on older Korean Americans, the proposed study aims to (1) develop an oral health education and navigation program that is personalized by a computerized tailoring system and delivered by community health workers (CHWs) and (2) pilot test the program to evaluate feasibility and acceptability.